Training Program in Molecular Biophysics of Complex Systems

This proposal to develop a new PhD Training Program in Molecular Biophysics of Complex Systems (MBCS) at
Oregon State University (OSU) connects mentors from six primary departments spanning three colleges at OSU.
Disciplines represented in the MBCS center around biological complex systems are broadly grouped under three
themes: 1) Data modeling and mining using computational methods, 2) Measuring and mapping using a broad
range of biophysical techniques, and 3) Making and modifying using and developing innovative technology for
better measurement and application tools. The MBCS mission with its focus on how biological complex systems
work at the molecular level, using a wide range of experimental (in vitro and in vivo) and computational (in silico)
techniques, will prepare Trainees for careers in molecular biomedical research at the interface of biophysics and
cell biology; there is broad demand in academia, industry, or national labs. Our objective is to provide MBCS
Program Trainees with a comprehensive and rigorous understanding of the fundamental underpinnings of
transdisciplinary research in scientific disciplines. Such training will result in innovative scientific advances that
benefit society. This Program will lower the barriers separating departments and colleges and facilitate
integration of the diffuse biophysics-related research and educational programs under one umbrella,
incorporating and coordinating the strength of each program. The 21 faculty Mentors provide extensive resources
for research, student support, and a highly collaborative training environment. Students will be selected from a
deep qualified pool of applicants using holistic admissions criteria, including dedication to science, research
background, and perseverance, in addition to quantitative metrics. New programs such as a Summer Head Start
for recruiting underrepresented minority, disabled or disadvantaged students will be supported as part of an
active institutional diversity program. We request five slots per year (steady state of ten students) to be supported
for the second and third year of graduate research. An additional slot per year will be funded by the institution.
New course development is included along with innovative tailoring of existing courses ranging from cellular
biophysics, molecular spectroscopy to mathematical modeling. Annual Summer workshops include theory and
hands on application of methodologies from nuclear magnetic resonance (NMR) to genetic code expansion to
workshops on new, cutting-edge techniques. Our intended outcomes are trained scientists, productive in their
research during and as measured by first-author publications, presentations at meetings, fellowships funding
and career outcomes which will be surveyed in our annual evaluations. Co-Program Director, Dr. Elisar Barbar
and Dr. Chong Fang are strong proponents of collaborative science, diversity, mentoring/Mentor training, and
innovative education; they have a successful history of funding and directing core facilities for the common good
(NMR for Barbar and Ultrafast Spectroscopy for Fang). Both have a history of mentoring women and
underrepresented groups in research. The faculty roster is highly collaborative and will model team science.

Public health relevance
Narrative A major challenge in the post COVID-19 and ChatGPT world involves harnessing students’ interest in science and innovation to solve important national and global problems. In this Molecular Biophysics of Complex Systems (MBCS) Program, we will train a new cadre of predoctoral students in collaborative, rigorous, accessible, and equitable science at the interface of physics, chemistry, biology, and engineering to reveal how life works, ultimately for the health benefit of all. We will build a molecular biophysics community at Oregon State University, working across departments and colleges, and strengthening biophysics in the State of Oregon using the following approaches: collaborative mentoring; programs to recruit and retain underrepresented groups in STEM (science, technology, engineering and mathematics); innovative methods to communicate science; and tailoring of existing and new university courses.